EFFECTS OF AGE ON INSULIN ACTION FOLLOWING ECCENTRIC EXERCISE

Resistance exercise training has been shown to have a positive effect on strength and functinal status in the elderly (4). However, an acute bout of resistance exercise causes muscle soreness and may lead to transitory insulin resistance. Aging is often associated with the development of insulin resistance, hyperinsulinemia, diabetes mellitus and coronary artery disease. The extent to which aging per se is responsible for these health problems is not clear, as a decline in physical activity and changes in body composition can also be major contributing factors. Data from this project will provide information on the extent to which basal and glucose-stimulated insulin action can be affected by resistance exercise which causes muscle soreness in young and older men and women. The results from this study can contribute to understanding the mechanism by which exercise can impact metabolic control in the elderly.